Spatial and temporal regulation of nutrient sensing

Project Summary / Abstract
Cells need to sense the nutrient availability to adjust their survival strategy. In eukaryotic cells, the
mechanistic Target of Rapamycin Complex 1 (mTORC1) is a key regulator of cell growth and proliferation.
Upon activation in a nutrient-rich environment, mTORC1 triggers anabolic reactions and inhibits catabolism.
Amino acid signals are transmitted to mTORC1 through a series of protein complexes that ultimately converge
on the Rag GTPases, a heterodimeric GTPase that recruits mTORC1 to the lysosomal surface. However, the
molecular mechanisms of how these protein complexes dynamically transmit the amino acid signal are still
elusive. In this proposal, we aim to develop biophysical tools to study the dynamics of the amino acid sensing
process. Specifically, we aim to use single molecule FRET to study the conformational dynamics of the Rag
GTPase heterodimer and its regulators (Project 1). Further, we plan to reconstitute an in vitro system to
recapitulate Rag-dependent amino acid sensing on a membrane surface (Project 2), and use cryo-electron
tomography (cryo-ET) to visualize the signaling complexes in their native environment (Project 3). The
outcomes will yield novel insights into this important biological process and provide guidance to the
development of therapeutic strategies.

Public health relevance
Project Narrative Cells need to respond quickly to the change of the nutrient level in the environment to adjust their survival strategy. The proposed research aims to investigate the dynamics of amino acid sensing using biophysical tools. We plan to recapitulate this biological process in vitro to gain fundamental understanding of how cells coordinate their behavior based on the nutrient availability.